PNNL PROTEOMICS AND THE UW P51 PRIMATE GENOME CENTER

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Apply PNNL high throughput comparative, quantitative proteomics for investigating disease states of non-human primates and their tissue pathologies as models for human disease.